Effectiveness RCT of Customized Adherence Enhancement

PROJECT SUMMARY/ABSTRACT
A cornerstone of treatment uniformly recommended for individuals with bipolar disorder (BD) is mood
stabilizing medication. However, approximately one in two individuals with BD are non -adherent with medication,
often leading to severe and negative consequences. Unfortunately, there is no widely used evidence-based
approach to target poor adherence in BD.
Customized Adherence Enhancement (CAE), developed by this study team, is a brief, practical BD -specific
approach that identifies individual adherence barriers and then targets these areas for intervention using a
flexibly-administered modular format. A prospective, 6-month, randomized controlled efficacy trial (RCT) of CAE
vs. a rigorous control, BD-specific education (EDU) found that medication adherence and functional status were
improved in CAE vs. EDU for poorly-adherent patients. Remarkably, the benefits of CAE occurred in individuals
who had been living with BD, on average, for over 2 decades. While promising, the original efficacy RCT was
limited by the fact that it was performed in an academic medical center, did not make use of existing web/text
messaging technology, and did not address potential challenges to scale -up in standard clinical settings.
In response to PA-18-722 “Improving Patient Adherence to Treatment and Prevention Regimens to Promote
Health”, this Type 1 hybrid effectiveness-implementation project will adapt CAE for use in community/public-
sector care settings, test effectiveness in high-risk, poorly adherent individuals in these settings, and gather
evidence on barriers and facilitators to implementation of the intervention in order to inform subsequent scale-
up. The project will examine putative mechanistic engagement targets suggested by previous work and include
implementation elements that will inform future dissemination should findings be positive. The project will be
implemented in 4 specific aims: 1) Refine the CAE intervention guided by stakeholders at a community mental
health clinic (CMHC) and a safety-net county healthcare system, 2) Test the effectiveness of technology-
facilitated CAE vs. enhanced treatment as usual (eTAU) using a prospective, 2-site RCT, 3) Test the effects of
CAE vs. eTAU on functional status in poorly adherent individuals with BD, and 4) Identify barriers and facilitators
to CAE implementation in order to inform subsequent scale-up and spread using qualitative methods and guided
by implementation conceptual models. Additional exploratory analysis will assess whether changes in patient-
level adherence barriers and facilitators mediate the treatment effects on adherence. Finally, the project will
evaluate on-site (outpatient visits, no-show rates) and off-site (emergency department visits, hospitalizations)
health resource use to help characterize relative value and inform future sustainability efforts. An over-arching
goal of this project will be to provide a curriculum-driven adherence enhancement approach that can be
implemented in public-sector care settings and which can improve outcomes for the most vulnerable groups of
people with BD.

Public health relevance
PROJECT NARRATIVE Approximately one in two individuals with bipolar disorder (BD) are non-adherent with medication, often leading to severe and negative consequences. Unfortunately,there is no widely used evidence -based approach to target poor adherence among individuals with BD. Building upon positive efficacy trial r esults, the proposed project will test the effectiveness of technology-facilitated Customized Adherence Enhancement (CAE) vs. enhanced treatment as usual (eTAU) using a prospective randomized controlled design in public mental health care settings and preferentially enrolling poorly adherent/high-risk individuals with BD. Deliverables include a curriculum-driven adherence enhancement approach that can be implemented in public healthcare settings and which can improve outcomes for the most vulnerable groups of people with BD.